Rakai Orphans in Communities

ROC Summary/Abstract
Loss of one or both parents can have devastating consequences for children, adolescents,
extended families, communities, and nations. Recently, improvements in HIV treatment and
prevention have led to dramatic declines in orphanhood. This appears to be the result of
combination HIV prevention (CHP), particularly expanded access to highly effective
antiretroviral therapy (ART) and declining HIV-related mortality among adults – adults who are
often parents. The declines in HIV-related orphanhood proffer substantial benefits to children
and youth, families, and their communities. Little is known about how declines in orphanhood
among youth may have impacted social and economic factors that influence HIV risk as
orphans move into the adolescent and young adult (AYA) years.
The Rakai Orphans in Communities (ROC) Study will explore impact, measurement, and
policy issues at the intersection of orphanhood, HIV risk among AYA, adolescent social
transitions, and family and social context. Impacts include HIV risk and social and economic
consequences. Measurement of age at orphaning will be a critical component of this proposal.
In several studies, earlier age at orphaning appears to be related to more adverse outcomes.
Thus, key issues are estimating the impact of orphanhood on social and behavior risk for HIV
and how that impact may change based on the age at orphaning. An under-explored component
which we will examine is the economic benefits of CHP weighed against the costs. Using the
rich resources of the Rakai Community Cohort Study (RCCS), we will explore the relationship
between HIV treatment and prevention, orphanhood, and new HIV infection among AYA.
Documenting the impact of CHP on HIV-related orphanhood and the decline HIV risk will guide
future investments in HIV treatment and prevention programs and health and social policies for
children and youth.

Public health relevance
ROC narrative HIV treatment and prevention in Rakai have led to dramatic declines in orphanhood. Measuring and understanding the relationship between HIV treatment and prevention, orphanhood, and new HIV infection among AYA will be essential in guiding future HIV prevention and social policies to promote child, adolescent, and young adult health. The ROC (Rakai Orphans in Communities) project will apply innovative qualitative and quantitative methods to broaden understanding of the impact of declining orphanhood on youth risk of HIV infection.